Sepsis Early Prediction and Subphenotype Illumination Study (SEPSIS)

PROJECT ABSTRACT
Sepsis, a life-threatening organ dysfunction syndrome due to infection, is common in hospitalized patients and
leads to significant morbidity, mortality, and costs. Over 1.7 million patients develop sepsis in the United States
each year, a number that will increase as the population ages. Patients with sepsis contribute to over $24 billion
in healthcare costs yearly, and a recent study found that sepsis contributed to up to half of hospital deaths.
Furthermore, survivors of sepsis suffer long-term cognitive impairment and physical disability. Therefore,
improving the care of patients with sepsis would be enormously beneficial to society. However, there are several
critical gaps in the field that need to be addressed: 1) delays in identifying infected patients are common and
associated with increased mortality; 2) errors in risk stratification of patients with impending critical illness and
sepsis are common and deadly; 3) current treatment strategies for infected patients utilize a one-size-fits-all
approach, which neglects the wide range of clinical presentations and underlying biology due to the complex
interactions between patient characteristics, the infectious organism, and the host immune response.
The overall vision of the PI’s research program is to address these knowledge gaps by utilizing detailed
multicenter electronic health record (EHR), clinical trial, and biomarker data combined with machine learning
approaches to improve the identification, risk stratification, and discover important subphenotypes of sepsis to
decrease preventable death from infection. Over the past five years, the PI has successfully secured independent
funding through an NIGMS R01 and Department of Defense award. The PI has published over 80 peer-reviewed
publications during this time, is an active member on several national and international committees, has
participated in several NIH study sections, and has 40 mentees, including six with NIH K-level awards.
Importantly, the PI has also developed and implemented a machine learning risk stratification tool, called eCART,
in over 20 hospitals, which has decreased mortality in high-risk ward patients. The goal of the next five years is
to build upon these successes and address key gaps in the field through three future directions: 1) using natural
language processing and deep learning to improve the identification and risk stratification of infected patients, 2)
identifying important subphenotypes using research biomarkers, and 3) using machine learning to develop
personalized treatment algorithms. These projects are innovative because they will utilize advanced machine
learning methods in a large, multicenter collection of structured and unstructured EHR and biomarker data for
developing novel tools in patients with sepsis. In the future, these models will be implemented for earlier
identification, accurate risk stratification, and to deliver personalized care at the bedside. This has the potential
to revolutionize the care of one of the most common and deadly conditions in hospitalized patients.

Public health relevance
PROJECT NARRATIVE The research program outlined in this proposal is relevant to public health because it will utilize detailed electronic health record, clinical trial, and biomarker data combined with machine learning to improve the identification, risk stratification, and discover important subphenotypes of sepsis to improve patient outcomes. This work will result in novel algorithms that can be implemented to deliver early, personalized care to decrease preventable morbidity and mortality from sepsis. Therefore, the proposed research is relevant to the part of the NIH’s mission that pertains to enhancing health, lengthening life, and reducing illness and disability.